Dissecting neuronal lipid metabolism

Project Summary
Dissecting neuronal lipid metabolism
PI: Thomas R. Clandinin
The brain is lipid rich, with the complexity of neural and glial membranes being fundamental to many
aspects of neural function. To function appropriately, neural and glial membranes must maintain a cell-type
appropriate composition of constituent lipids, and must continue to do so across adult life, even as ongoing
vesicle fusion and retrieval make the control of lipid metabolism a fundamental challenge. At the same time,
mutations that disrupt the biosynthesis and recycling of membrane lipids are associated with a large number of
neurodegenerative diseases, making understanding how membrane lipids are produced, degraded, and
recycled a problem of central interest. How is the lipid composition of specific cell types regulated in the adult
brain, and how do alterations in lipid composition affect brain function in health and disease?
This proposal focuses on the biosynthesis of glycosphingolipids, key constituents of neural and glial
membranes that are evolutionarily conserved across metazoans, including humans. One of the genes
involved in glycosphingolipid metabolism, Glucocerebrosidase (Gba) is associated with Parkinson’s Disease
risk, as well as Gaucher Disease. However, how Gba acts in the adult brain remains incompletely understood.
This proposal takes advantage of the evolutionarily conserved nature of Gba, using the fruit fly as a model to
dissect the relative contributions of glia and neurons to Gba function. We focus specifically on two key
questions. First, how is Gba function regulated by neural and glial activity? And second, how is Gba activity
programmed during development, and transcriptionally regulated in adult neurons?
These studies will broadly inform our understanding of how neural function is maintained across adult
life, and dysregulated in neurodegenerative disease. As this understanding is fundamental to the development
of novel drugs that modulate these pathways to prevent disease, these studies will broadly inform future
therapeutic strategies.

Public health relevance
Project Narrative Dissecting neuronal lipid metabolism PI: Thomas R. Clandinin Understanding how neurons and glia coordinate the control of membrane function is crucial to brain function in both health and disease. This project dissects the functions of genes and proteins that control how neuronal membranes are made and recycled in order to understand how these processes are regulated. The results of this work will broadly inform therapeutic strategies for neurodegenerative diseases like Parkinson’s Disease.